Remote Data Enclave Core

Project Summary
Remote Data Enclave Core (Core E)
The Remote Data Enclave Core (Core E) will provide a Virtual Data Enclave to facilitate access
to restricted aging-related data to advance research on the demography of aging. The enclave
has two overarching goals: (1) To provide researchers around the world with efficient and secure
access to aging-related restricted-use data from NIA-funded studies; and (2) To support MiCDA
affiliates conducting aging-related projects and collaborations with restricted-use data. In the
coming cycle we will achieve these goals by (1) Expanding the MiCDA enclave's data products
and user base by: continuing partnerships with the Health and Retirement Study and Panel Study
of Income Dynamics and building new partnerships with other NIA-funded studies; building new
collaborations to make geographic data available for use with partner studies; and for local MiCDA
affiliates, expanding increasing awareness and streamlining the application process. (2) Ensuring
continued reliable system performance by: regularly reviewing, expanding and upgrading
hardware and software infrastructure; and instituting routine reporting of system performance and
capacity metrics to help avoid or swiftly diagnose and address performance problems.